DATA ANALYSIS AND STATISTICAL PROGRAMMING SUPPORT FOR DIPHR

The purpose of this contract is to provide onsite statistical, data management, data collections, analysis and reporting support for the Division of Intramural Population Health Research